High Throughput Lipidomic Profiling with High Structural Specificity for Phenotypic Screening

PROJECT ABSTRACT
Lipids are a diverse class of biomolecules that play pivotal roles in various cellular processes and have
been implicated in the pathogenesis of diseases such as diabetes, Alzheimer's, Parkinson's, and various
cancers. Understanding lipid structures and functions is crucial for unraveling their roles in complex biological
systems and diseases. Unambiguous identification of lipids, particularly with high-level structural details and
separation of lipid isomers, has been an analytical challenge. However, such knowledge is essential for
obtaining a full understanding of lipid functions and discovering lipid biomarkers for diseases. Addressing the
absence of rapid lipid profiling methods and that provide sufficient structural details is critical for predicting,
controlling, and engineering lipid metabolism on a large scale for biomedical and phenotypic screening. My
long-term goal is to enable the elucidation of the detailed molecular mechanisms of lipid metabolism through
advancing lipidomic profiling with high structural specificity and to unravel the relationship between specific
lipids and associated functions in biological systems and diseases. To achieve this, we propose developing a
next-generation lipidomics pipeline using mass spectrometry-based technologies and advanced bioinformatics
capabilities. Our approach involves developing a multi-dimensional lipidomic platform using high-resolution
structures for lossless ion manipulations-based ion mobility spectrometry-mass spectrometry, advanced
fragmentation techniques, and gas-phase reactions for effective lipid structure elucidation, including resolved
isomer separation and determining double bond locations. This integrative platform will be coupled with liquid
chromatography and a novel data acquisition approach utilizing both data-dependent acquisition and data-
independent acquisition for a comprehensive analysis of lipids in complex samples. To ensure robust data
processing, lipid identification and structure elucidation, we will develop advanced bioinformatics pipelines
using artificial intelligence approaches. Additionally, a high-throughput and quantitative workflow utilizing online
solid-phase extraction for rapid lipid screening will be developed. The robustness of this workflow and
advanced bioinformatics pipeline will be validated by fully profiling the yeast lipidome. A comprehensive and
structurally detailed lipid atlas for the yeast knockout collection will be constructed and provide a foundation for
understanding lipid metabolism and associated functions analogous to human genes. We anticipate that this
platform will become a fundamental capability for lipid profiling in biomedical research to unravel the intricate
relationship between lipids and associated functions in biological systems and human health. Furthermore, we
expect this innovative approach to facilitate the discovery of lipid biomarkers for disease diagnostics and drug
development.

Public health relevance
PROJECT NARRATIVE The complete identification of lipids is critical for a better understanding of the roles of lipids in biological system and diseases. This project aims to develop a next generation lipidomics platform for in-depth lipid profiling with high structural specificity through advanced mass spectrometry technologies and bioinformatics pipelines. We anticipate this platform will become a fundamental tool for lipid profiling in biomedical research to unravel the relationship between lipids and associated functions in biological systems and human health.